Integration, optimization, and expansion of computational tools and resources for the Caenorhabditis Natural Diversity Resource

Project Summary
The goal of this application is to support Michael Sauria, PhD, as a Research Software Engineer (RSE) in the
Andersen lab in the Department of Biology at Johns Hopkins University. He currently helps administer the
Caenorhabditis Natural Diversity Resource (CaeNDR) under the direction of Erik Andersen, PhD. This project
uses natural variation across three species of nematodes and thousands of strains to provide insights and
resources for discovery not otherwise possible in genetically homogenous model organisms, such as natural
differences in toxicant response and drug resistance in closely related parasitic nematodes. This RSE role will
support several funded NIH projects by Andersen and many others by additional investigators across the
evolutionary genetics and Caenorhabditis communities. In order to thrive and expand, CaeNDR requires a
dedicated RSE, something it has been lacking since the Andersen lab moved from Northwestern University a
year ago. This grant would provide Dr. Sauria the dedicated time necessary to oversee this project. In
particular, he will overhaul the underlying infrastructure, including rebuilding the analysis pipelines to add
robustness, flexibility, and quality assurance as well as migrating the project from Google Cloud Platform to
Amazon Web Services. Dr. Sauria will develop additional tools and resources available to CaeNDR users to
make better use of the hosted variation data, including strain-specific CRISPR-Cas9 guide RNA design,
genome-wide association mapping tools in C. briggsae and C. tropicalis, sister species to C. elegans, and
evolutionary statistics. Finally, Dr. Sauria will improve the user experience and user interface of CaeNDR by
developing interactive tools for real-time data exploration, guided site and tool walkthroughs, and extensive
documentation to support the analysis workflows as their own resource. Ultimately, this grant will support the
harmonization of CaeNDR as a benchmark for other model systems, such as yeast, fly, and mouse, so that
similar tools can be added to the Alliance of Genome Resources, leveraging natural variation as a powerful
discovery platform.

Public health relevance
Project Narrative The CaeNDR project, a data and tool resource for natural variation in three Caenorhabditis species, serves as an invaluable resource for leveraging diversity to understand fundamental mechanisms such as variation in toxicant and drug resistance. Coupling detailed environmental data with phenotypic and genotypic data for thousands of diverse populations, CaeNDR provides a powerful means of connecting behaviors, environmental responses, toxicant sensitivities, and more to specific variants, providing valuable insights into molecular mechanisms. With expansion of tools, datasets, and analyses to enable direct genetic manipulation, I will make CaeNDR a benchmark for enabling discovery of causal mechanisms and interventions in model organisms using naturally occurring variation.